Admin Core A

The overarching goal for Administrative Core A will be to facilitate the research activities of this
Program Project, thereby enabling Program members to focus on scientific progress. This Core
will (1) Assume responsibility for Program oversight to ensure that all work carried out meets
requirements established by the National Cancer Institute and the National Institutes of Health,
(2) Provide financial oversight to the Principle Investigator, Project Leaders, and Core
Directors, (3) Organize and coordinate meetings among Project Leaders, Core Directors, and
their associated laboratories, (4) Facilitate and coordinate effective communication between
Project Leaders and the External Advisory Board, and (5) Organize Program Project-related
travel and facilitate submission of manuscripts. The personnel responsible for Core A include
Dr. Roger Greenberg (Principal Investigator and Project 1 Leader), and Mrs. Laura Murillo,
Director of Administration for the Penn Center for Genome Integrity (PCGI). In addition to her
support for Dr. Greenberg and this Core, Mrs. Murillo will assist all Project and Core Leaders
across this P01 with the daily management of all scientific aspects (research meetings,
seminars, manuscript, and progress report preparations) and resources (budget allocation,
expense reports, and Core usage monitoring) for all projects and cores. As the Principal
Investigator and Core A Director, Dr. Greenberg will take primary responsibility of this Core’s
functions, which includes providing direction for Mrs. Murillo. In this role, Dr. Greenberg will
meet frequently with the Project and Core leaders to jointly discuss the overall direction of the
research. Mrs. Murillo will serve as coordinator in scheduling these meetings and will also
meet weekly (or more frequently as needed) with Dr. Greenberg.

Public health relevance
Narrative The major goal for The Administrative Core A will be to facilitate the research activities of this Program Project, thereby enabling Program members to focus on scientific progress. As the Principal Investigator and Core A Director, Dr. Greenberg will take primary responsibility of this Core’s functions, which includes providing direction for Mrs. Murillo. In this role, Dr. Greenberg will meet frequently with the Project and Core leaders to jointly discuss the overall direction of the research.